Impact of chronic alcohol consumption on the functional and epigenetic landscapes of monocytes and their progenitors

PROJECT SUMMARY
Approximately ~7% of alcohol-consuming individuals engage in chronic heavy drinking (CHD), which is
associated with increased susceptibility to infections as well as impaired wound healing and tissue repair
resulting in poor post-operative outcomes. Evidence suggests that many of these defects are mediated by
excessive inflammatory responses originating from myeloid cells, notably circulating monocytes and tissue-
resident macrophages. These data were primarily generated from in vitro studies where monocytes from healthy
donors or cell lines are treated high doses of ethanol. However, the mechanisms underlying the effects of CHD
cannot be fully understood by in vitro studies because immune cells carry out their functions in a multicellular
environment in which alcohol has widespread effects. Due to a lack of studies utilizing reliable in vivo models,
our understanding of the mechanisms underlying aberrant inflammatory responses in the context of CHD
remains incomplete. To address these knowledge gaps, we propose to leverage a rhesus macaque model of
voluntary ethanol self-administration that accurately mirrors human physiology and recapitulates complex human
drinking behavior. Using this model, our lab has recently demonstrated that CHD results in transcriptional and
epigenetic rewiring of circulating monocytes and splenic macrophages, resulting in aberrant responses to LPS
stimulation. However, the functional implications of this reprogramming and the epigenetic mechanisms
controlling it remain unknown. Importantly, because monocytes are short-lived circulating cells under constant
repopulation from the bone marrow, these observations suggest perturbations of the hematopoietic niche.
Preliminary single-cell analyses of hematopoietic progenitors point to a shift in differentiation potential towards
more mature myeloid progenitors with alcohol. However, a link between this observation in progenitor cells and
their differentiated states in blood and tissue remains unclear. In this application, we propose to test the
hypothesis that chronic alcohol consumption reprograms the epigenetic landscape of monocyte
progenitors in the bone marrow giving rise to circulating monocytes poised towards a hyper-
inflammatory response. We will first examine the impact of CHD on functional reprogramming of circulating
monocytes, implementing assays to test their ability to migrate, phagocytose, and generate proper metabolic
responses. We will next examine the effect of stimulation on the monocyte epigenetic landscape through
assessment of chromatin accessibility and abundance of specific histone modifications. Finally, we will determine
the effect of CHD on the differentiation potential, transcriptome activation, and epigenetic rewiring of bone
marrow myeloid progenitors and integrate these data with those obtained from peripheral blood monocytes.
Completion of this proposal will provide novel insight into the impact of CHD on myelopoiesis and mechanisms
by which it compromised immunity and host defense as well as design interventions to mitigate these adverse
events and improve immunological outcomes.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Approximately 7% of alcohol users engage in chronic heavy drinking (CHD), which is associated with increased risk of bacterial and viral infections as well as decreased tissue repair ability. These observations suggest a failure of innate immune cells to perform their functions. The proposed research aims to identify CHD-mediated functional, transcriptomic, and epigenetic alterations in monocytes and their progenitors in the bone marrow, with the goal of better understanding the etiology of reduced immune fitness.